Disentangling the specific contributions of different dorsal root ganglia neuron types to pain representation in the brain.

Pain is a multi-layered experience. It typically begins with nociception, the process by which noxious sensory
signals are communicated through the peripheral and central nervous system. Peripheral signals are carried by
various somatosensory neurons residing in the dorsal root ganglia (DRG) and trigeminal ganglia (TG). With the
advent of innovative techniques like optogenetics and chemogenetics, researchers can now selectively
modulate the activity of different classes of DRG neurons, offering insights on their specific roles in pain
transmission. However, a comprehensive functional mapping of each molecularly defined DRG neuron types,
especially in the context of chronic pain, has yet to be conducted. Furthermore, the effect of chemogenetic
inhibition of DRG neurons on pain-induced neuronal activity in the brain has never been studied, leaving a gap
in understanding the contribution of these primary afferent neurons to pain experience.
I have successfully conducted the in vivo validation of a novel peripherally restricted designer receptor
exclusively activated by designer drug (DREADD), in collaboration with Dr. Bryan Roth. This new tool enables
us to use chemogenetics to inhibit DRG neurons without off-target effects. In this proposal, I aim to use this
DREADD to: 1) establish a comprehensive functional map of molecularly defined DRG neuron types, 2)
interrogate how distinct DRG neuron types can change the representation of pain in the brain, and 3) record and
identify the cerebral neurons that directly respond to these peripheral manipulations.
To create this functional map, I will combine our novel DREADD with mouse genetic tools to inhibit distinct
classes of DRG neurons and assess their role in various types of pain. Then, to pinpoint the different brain
structures that shut down their activity following peripheral inhibition, I will employ iDISCO+ whole-brain clearing,
c-FOS immunostaining, and light-sheet microscopy. Lastly, to accurately record changes in the neuronal activity
of relevant brain regions and identify antinociceptive neurons, I will combine two-photon in vivo microscopy with
spatial transcriptomics. Altogether this project will determine whether different classes of DRG neurons can
differentially contribute to acute and chronic pain experiences through the modulation of different neuronal
ensembles in the brain.
This research will occur in Dr. Grégory Scherrer’s laboratory at the University of North Carolina at Chapel Hill,
an ideal environment for innovative research in the neurobiology of pain. With mentorship and guidance from
esteemed neuroscientists Drs. Roth, Zylka, Ross, Schnitzer, and Ariel, this endeavor will greatly enrich my
expertise in pain research, immersing me in cutting-edge techniques and concepts while filling critical gaps in
knowledge in the pain field. Ultimately, this project will pave the way for my transition to an independent faculty
position, ideally initiating my own laboratory program studying pain and associated comorbidities with a unique
but holistic focus, the DRG-brain axis.

Public health relevance
Project Narrative Chronic pain, a global debilitating disorder affecting 20% of the population worldwide, is typically mediated by neural signals rising from the dorsal root ganglia (DRG) to the brain. Despite advancements in our fundamental understanding of pain pathways, it remains unclear how changes in the activity of different classes of DRG neurons affect neuronal activity in the brain to modulate chronic pain experience. This proposal aims to meticulously elucidate the contribution of specific DRG neuron types to pain representation in the brain.